Neural correlates and behavioral impact of withdrawal-induced hyperalgesia among people who smoke with and without chronic pain

Tobacco smoking is extremely addictive and remains a leading cause of preventable death.
Individuals with chronic pain are approximately twice as likely to smoke cigarettes as those
without pain, and smoking cessation among people with comorbid pain is more difficult to
achieve. Smoking and pain have been proposed to influence each other through a maladaptive
reciprocal positive feedback loop, in which pain increases motivation to smoke and smoking
worsens pain over time. Moreover, smoking withdrawal exacerbates pain, thus presenting an
additional barrier to smoking cessation. However, the mechanisms underlying withdrawal-
induced exacerbation of pain (hyperalgesia) and the real-world impact of withdrawal-induced
hyperalgesia among people attempting to stop smoking, remain unclear. To fill this important
scientific gap, we will evaluate among people who smoke (PWS) with and without chronic pain:
1) the impact of smoking withdrawal on brain fMRI-based response to noxious heat stimuli (Aim
1); and 2) the influences of withdrawal-induced hyperalgesia on the ability to abstain from
smoking (Aim 2). Adults who smoke daily with (n=48) and without (n=48) chronic pain will each
complete 2 fMRI scans with counterbalanced conditions: after smoking ad libitum, and after 24-
hrs biochemically verified abstinence. During the fMRI scans, participants will experience and
provide pain ratings to a pseudorandom series of neutral and noxious heat stimuli. Participants
will complete a 1-week abstinence test with a descending reinforcement schedule previously
used by our group, accompanied by ecological momentary assessment (EMA) of pain, affect,
and smoking urge. We hypothesize based on our preliminary data that: 1) increased pain during
smoking withdrawal will correlate with decreased activation of the bilateral inferior frontal gyrus
(IFG) indicating reduced cognitive-affective regulation of pain; 2) PWS with chronic pain will
exhibit greater withdrawal-induced deficits in IFG activation; and 3) Chronic pain status and
withdrawal-induced changes in pain ratings and pain-related brain activation will predict shorter
time to lapse. By addressing a critical gap in scientific knowledge regarding the neural basis and
behavioral impact of smoking withdrawal-induced hyperalgesia, the project will provide a
foundation for development of targeted behavioral, pharmacological, and neurostimulation
interventions to aid smoking cessation.

Public health relevance
Project Narrative Individuals with chronic pain are more likely to smoke cigarettes and have more difficulty quitting smoking than the general population, in part because withdrawal from smoking can lead to temporary increases in pain. This research will examine how smoking withdrawal changes the way the brain processes pain, and whether these withdrawal-related changes interfere with the ability to stop smoking. The results of this research will provide important information that can be used to guide the development of interventions to help people with chronic pain who smoke cigarettes to quit smoking and improve their health.